Clinical Center for Cholestatic Liver Disease in Children

PROJECT SUMMARY/ABSTRACT
We propose to recruit Dr. Cyd Castro-Rojas as Clinical Research Coordinator (CRC) to the multicenter
Childhood Liver Disease Research Network (ChiLDReN) to broaden the research workforce for this program
and improve enrollment and retention of all populations affected by the cholestatic liver disease, i.e. extrahepatic
biliary atresia (EHBA), primary sclerosing cholangitis (PSC), or Alagille syndrome, into the ChiLDReN
longitudinal study protocols. Preliminary published data indicate that racial, ethnic, and socioeconomic disparities
impact timely diagnosis and access to biliary drainage surgery in EHBA and natural history in PSC. Therefore, it
is important that natural history studies on these conditions adequately represent all populations at risk. Using
enrollment and retention logs for ChiLDReN studies and electronic health records for patients cared for in
Cincinnati, we discovered trends for decreased enrollment of Black and Asian infants with EHBA into the PROBE
and BASIC protocols and lower retention rates for Blacks and patients with EHBA of Hispanic ethnicity in the
PROBE study. We hypothesize that broadening the research staff for ChiLDReN will allow us to successfully
implement strategies to improve recruitment and retention of study participants from a diverse racial, ethnic, and
socioeconomic background into ChiLDReN protocols.
Dr. Castro-Rojas will broaden the clinical research workforce and improve the enrollment and retention of study
participants from diverse backgrounds into the ChiLDReN protocols by 20%. She will lead improvement efforts
for the ChiLDReN research program at Cincinnati, including building relations with Black, Hispanic, and
socioeconomically disadvantaged communities through the Research Participant Advisory Group. Dr. Castro-
Rojas will seek the advisory group’s guidance in editing study documents to make those more approachable for
all populations and in identifying strategies to remove barriers to research activities by participants at risk. She
will take a 12-credit course at the University of Cincinnati to obtain the Graduate Certificate in Community-
Engaged Research for Health and apply the learnings to the improvement efforts for the ChiLDReN network.
Additionally, she will take targeted training through the Association of Clinical Research Professionals and the
CITI Program to learn about best practices and strategies for recruiting and retaining participants from diverse
communities. Furthermore, Dr. Castro-Rojas will disseminate insights into successful research improvement
efforts to reduce disparities in observational studies with other ChiLDReN sites and across NIDDK-supported
studies at Cincinnati.

Public health relevance
PROJECT NARRATIVE We propose to recruit Dr. Cyd Castro-Rojas as Clinical Research Coordinator (CRC) to the Childhood Liver Disease Research Network (ChiLDReN). She will develop the tools to improve recruitment and retention of children with cholestatic liver disease from underrepresented minorities into the ChiLDreN protocols in Cincinnati to enhance accuracy and generalizability of the longitudinal studies of ChiLDreN on natural history and on modifiable and non-modifiable risk factors for progression of biliary atresia, primary sclerosing cholangitis, and other cholestatic liver diseases.